Remotely-Delivered Cognitive Behavioral Stress Management Effects on Cancer-Accelerated Aging in Older, Distressed Breast Cancer Survivors

Protocol Synopsis-Brief Summary
Study Overview. We will enroll Breast Cancer Survivors (BCS) who completed initial treatment
within 3 – 12 months which may or may not have included chemotherapy, are continuing
on adjuvant endocrine therapy (AET), who are distressed, mid-older aged (> 50yrs), post-
menopausal, and were diagnosed with Stage I – III HR+ (ER/PR+), Her2neu- breast cancer.
We will have a brief run-in period starting just after treatment completion (i.e., waiting period
prior to randomization) where potentially eligible participants will undergo screening. At least 3
months and up to 12 months after the completion of initial treatment they will be asked to
complete a baseline assessment over REDCAP, collect saliva samples over 2 consecutive days
(4 times daily) in the same week to assess Area Under the Curve (AUC) and diurnal salivary
cortisol slopes, wear an Empatica wristband to collect heart rate variability (HRV) to index
parasympathetic nervous system activity, and attend an in-person visit for blood draw. A total of
192 participants who complete the run-in period will be block randomized (on the basis of
receiving or not receiving chemotherapy) to receive either: 1) Remotely-delivered Cognitive
Behavioral Stress Management (R-CBSM) + Survivorship Care Planning (SCP) (n = 96); or 2)
SCP-only control (n = 96). After randomization, participants assigned to R-CBSM+SCP receive
a link to attend 10 weekly group R-CBSM sessions by ZOOM and are provided access to a
website containing education materials corresponding to stress management modules. During
the intent-to-treat period, we monitor weekly changes in intervention processes (stress, mood,
perceived stress management skills, emotion regulation) via ecological momentary assessment
(EMA) to mobile phones or will use paper diary. After the interventions are completed follow-up
assessments at 6 and 12 months are completed via RedCap questionnaires, saliva (cortisol),
wristbands (for HRV) and blood (immune measures) to characterize intermediary improvements
in psychological adaptation, and neuroimmune regulation. Participants are also assessed for
physical (longer-term immune cell senescence) and mental health (depression, quality of life)
over 0, 6, 12 and 24 months with questionnaires or interviews (remote or in-person), and blood
draws. In total they will complete 4 visits (T1: 0m, T2: 6m, T3:12m, T4: 24m) as well as remote
intercurrent monitoring of intervention processes over the 0- 3 month training period for both the
R-CBSM+SCP and SCP-only conditions. Monitoring intervention process changes will be a
manipulation check and will inform whether these changes are specific to R-CBSM and whether
they are correlated with changes in intermediary regulatory variables.

Public health relevance
PROJECT NARRATIVE A major focus of the study is in using a remotely-delivered group-based cognitive behavioral stress management (R-CBSM) intervention to prevent physical and mental health decline in the vulnerable population of distressed, older breast cancer survivors (BCS). The scientific model of the study holds that cancer, its treatments and other sequelae bring about challenges for psychological adaptation and neuroimmune regulation after the completion of treatment, which if persisting may conspire to accelerate the natural aging process (i.e., Cancer-Accelerated Aging, CAA) to promote long-term negative physical (e.g., immune cell senescence) and mental health (e.g., depression, poor quality of life) outcomes. The premise of the study is that a R-CBSM intervention designed to improve modifiable processes affecting psychological adaptation and related neuroimmune regulation may interrupt this process to promote better long-term physical and mental health outcomes. This is the first randomized controlled trial to test the effects of a R-CBSM intervention on CAA and health outcomes in older, distressed HR+ Her2neu BCS over a 24-month period in cancer survivorship following treatment completion. It is highly relevant for the NIH notice of special interest for use of telehealth in cancer care (NOT-CA-21-043).